Innate-like lymphocyte regulation of host-microbiota interactions in cancer

PROJECT ABSTRACT
Host-microbe interactions profoundly impact cancer. This is exemplified by well-documented infections that
promote cancer, and the ability to prevent these cancers through vaccination or pathogen avoidance. However,
humans are densely colonized with trillions of normally beneficial microbes, termed the microbiota, which also
have the ability to promote cancers through the induction of inflammation or genomic instability. Further, recent
seminal studies demonstrated that intestinal microbiota are also required for anti-tumor immunity in the context
of therapeutic interventions, such as checkpoint blockade. Despite these advances, the specific pathways by
which microbiota shape pro- versus anti-tumor immunity remain poorly defined, and the potential relevance of
these findings to specific types of cancer are unknown. The fundamental focus of supplemental application
is to support training of a graduate student candidate who will interrogate the role of innate-like
lymphocytes in shaping host-microbiota interactions that protect from tumor progression and promote
the efficacy of immunotherapies in colorectal cancer (CRC). This will be an outstanding opportunity for the
candidate to grow as an independent scientist and test the proposed novel hypotheses that are directly
relevant to the parent R01 for this proposal. Expected outcomes are for this candidate to be highly successful
in embedding within the scientific community, executing the proposed experiments, and analyzing data that
could provoke a paradigm shift in our understanding of how interactions between immune cells and the
intestinal microbiota shape colorectal cancer induction, progression, or immunotherapy response.

Public health relevance
PROJECT NARRATIVE Cancer is major socio-economic problem in the United States, with annual estimates at 1.7 million new diagnoses, over 600,000 cancer-related deaths, and health care costs exceeding 125 billion dollars. The focus of this proposal is to develop novel approaches that modulate selective host-microbiota interactions to limit tumor progression and improve the efficacy of checkpoint inhibitors in colorectal cancer.